Core A - Admin Core

Abstract
The Administrative Core provides integration and management of activities for the MDSRC. It promotes
interactions and communications between the research and patient/advocacy communities on both a national
and local level. The Administrative Core maintains our website to communicate the Center's mission and the
availability of training opportunities and services available through our Shared Scientific Resource Core. The
core also coordinates meetings with our Center Advisory Committee (CAC) that has scientific, clinical and
patient advocate representation. The CAC meets in-person and/or electronically once a year. The
Administrative Core also works in conjunction with our Center members to promote awareness of muscular
dystrophy research and the Wellstone Centers program in the patient/advocacy communities. Our
Administrative Core has developed outreach activities as well as meetings, seminars, web-based information,
and lab tours involving patients and their families interacting with our investigators. The Administrative Core
also manages the matching funds we have received both internally and from patient advocacy groups.